Factor VIIa-released extracellular vesicles: Their role in hemostasis and beyond

Clotting factor VIIa (FVIIa) initiates the activation of the coagulation cascade by binding to the procoagulant
cofactor tissue factor. Recombinant FVIIa is a clinically approved drug for treating bleeding in hemophilia patients
with inhibitors and other bleeding disorders. It is also used off-label to treat severe bleeding associated with
surgery, liver disease, and intracerebral hemorrhage. We have discovered that FVIIa also binds to the
anticoagulant cofactor, endothelial cell protein C receptor (EPCR). FVIIa binding to EPCR modulates protein
C/activated protein C-mediated anticoagulant pathway. Our studies also established that FVIIa-EPCR activates
protease-activated receptor 1 (PAR1)-induced biased cell signaling, resulting in anti-inflammatory and vascular
barrier protective effects. Interestingly, our recent studies revealed that FVIIa-EPCR-PAR1-mediated biased
signaling induces the release of extracellular vesicles (EVs) from endothelial cells (EEVs). These vesicles are
found to exhibit hemostatic and anti-inflammatory properties. EVs are increasingly recognized as important
mediators of intercellular communication, play an important role in various pathophysiological processes, and
likely have immense therapeutic potential. Understanding the biogenesis and release of FVIIa-generated EVs,
characterizing their cargo, interactions with recipient cells, and their behavior in vivo is crucial for assessing their
role in pathophysiology and fully capitalizing on their therapeutic and drug delivery potential. The proposed aims
are designed to address these important knowledge gaps. Our overall hypothesis is that FVIIa-released EVs
contribute to hemostatic, anti-inflammatory, and vascular barrier protective effects by communicating with other
cell types by transferring their unique cargo. These EVs hold therapeutic potential in treating bleeding disorders,
inflammation, and hemophilic arthropathy. The specific aims are, Aim 1: Investigate the hypothesis that FVIIa-
released EEVs are unique and distinct from EEVs released by other coagulation proteases. Aim 2: Elucidate the
mechanism of FVIIa-released EV biogenesis, phosphatidylserine (PS) enrichment of FVIIa-released EEVs, and
their distribution and fate in vivo. Aim 3: Determine the role of FVIIa-released EEVs in hemostasis and
inflammation and elucidate potential mechanisms. Aim 4: Determine the effect of FVIIa-released EEVs in the
treatment of hemophilic arthropathy (HA) and explore the potential contribution of miR10a, found in the cargo of
FVIIa-released EEVs, to this process. In these proposed studies, we will employ an unbiased omics approach
to characterize FVIIa-released EEVs. We will also use loss- and gain-of-functional studies, unique transgenic
mice, and murine model systems of bleeding, hemophilic arthropathy, and inflammation. The knowledge gained
from our studies will not only lead to more efficient and cost-effective clinical treatments for hemophilia patients
but also lead to novel therapeutic strategies for bleeding and inflammatory disorders. Our studies will contribute
to a paradigm shift in our current understanding of proteases-induced cell signaling and their potential to affect
cellular processes in distant cells through communication via EVs.

Public health relevance
PROJECT NARRATIVE The proposed studies will address the pathophysiological significance and therapeutic potential of our recent novel observations that clotting factor VIIa releases extracellular vesicles (EVs) from endothelial cells. Our studies will provide mechanistic insights into how factor VIIa generates these vesicles and influences hemostasis, inflammation, and barrier integrity directly or by communicating with other cell types through cargo delivery from EVs to recipient cells. The knowledge gained from our proposed studies will have enormous significance in improving current therapeutic options for treating bleeding and inflammatory disorders and opening new therapeutic modalities.